Non-canonical functions of chromatin insulators and Polycomb-group proteins

Changes in gene transcription are important in the progression of cancer, in most other human diseases, and
in the aging process, as well as in the development of multicellular organisms at all stages. A full
understanding of how such changes are regulated is the basis of diagnostic tools and intervention strategies.
Further advancement holds the promise of novel approaches, and of increased effectiveness of current
approaches. Tools available in Drosophila make it possible to study gene regulatory mechanisms in great
detail, in a true in vivo context. This proposal is to study mechanisms of chromatin-based gene regulation
involving Polycomb-response elements (PREs) and insulators (including one named homie) that are found in
the well-characterized Drosophila gene even skipped. These studies will address basic questions of how
regulatory DNA that mediates transcriptional memory and chromosome organization carries out its function in
3 dimensions in the nucleus. They will provide a clearer understanding of how epigenetic mechanisms
propagate alternative transcriptional states, and how chromosomal domain organization affects gene
expression. A unique contribution of these studies is to integrate these mechanisms with those mediating
enhancer-promoter interactions in a developmental context. In mammals, Polycomb-group proteins and
insulators are involved in the maintenance of stem cell identity, developmental decisions, and dosage
compensation, as well as in oncogenesis and inherited human disorders. The Specific Aims are:
Aim 1. Determine how the conserved, DNA binding Polycomb-group (PcG) protein Pleiohomeotic (Pho)
maintains both the active and the repressed state of Drosophila even skipped (eve) gene expression.
Determine how novel epigenetic mechanisms that regulate eve are deployed genome-wide.
Results from these studies will propel the field of epigenetic gene regulation into novel territory, uncovering
entirely new influences on both development and adult tissue maintenance.
Aim 2. Determine how read-through transcription represses enhancer function and how this repression is
influenced by Polycomb domains, at eve and throughout the genome.
Studies here will explore a new way in which the very act of transcription regulates genes, leading to
mechanistic insights that apply genome-wide.
Aim 3. Determine mechanisms whereby some promoters initiate highly processive transcription that reads
through barriers, such as poly(A) addition signals, while others do not.
Processive transcription has the power to influence gene expression and chromosome architecture over great
distances along a chromosome. Its regulation and influence are just beginning to be understood. We have
developed a sensitive assay system that will allow us to make rapid progress toward a mechanistic
understanding.

Public health relevance
Project Narrative Changes in gene transcription are important in the development and progression of most human diseases, in inherited disorders and the aging process, and in embryonic development. A detailed understanding of how such changes are regulated is the basis for diagnostic tools and intervention strategies, and is the general subject of this proposal. It will uncover novel aspects of fundamental biological mechanisms that apply to all eukaryotic organisms, leading toward novel approaches, and increasingly effective interventions, in the diagnosis, treatment and prevention of human disease.